NEW ALGORITHMS FOR ELECTRONIC STRUCTURE &MOLECULAR MODELING CALCULATIONS

In this research we are developoing new methods for quantum chemistry (both SCF and electron correlation methodologies), molecular dynamics, and protein folding simulations. In all cases, the codes have been highly optimized and demisntrate superior performance when compared to plausible alternatives; both serial and massively parallel implementations are being pursued. Applications include understanding charge separation in the photosynthetic reaction center, determination of protein structure froma minimal set of NMR data, and studies of helix stability via quantum chemical calculations in solution.